Examining Anti-Racist Healing in Nature to Protect Telomeres of Transitional Age BIPOC for Health Equity.

Deaths from chronic diseases are disproportionately higher in communities of color. This is expected given the
well-documented health inequities in the United States caused by centuries-old underinvestment in their
wellness. To begin to redress this underinvestment during an economic crisis requires cost-effective, low-
resource interventions. It also requires community engagement to ensure uptake and sustainability. Therefore,
we propose to undertake community-prioritized research that will engage ancestral knowledges from different
communities of color in a multilevel effort to address growing health disparities via intersectoral collaborations.
The overall goal of our transformative Reclaiming Nature project is to reduce growing health
disparities in Black, Indigenous, and People of Color (BIPOC) communities through examination of
culturally-appropriate interventions. These are aimed at reducing embodied stress in transitional-age
BIPOC so as to prevent their development of chronic diseases as adults. The development of chronic
diseases has been linked to the embodiment of stress through biological processes that include cortisol
dysregulation and telomere erosion. In fact, emerging research from several research groups, including our
own, finds that erosion of telomere in communities of color is accelerated. This is likely due to racism and
discrimination that increase chronic stress and limits access to the social determinants of health (e.g.,
employment, education, housing). We thus aim to reduce embodied stress through increased access to what
can be considered a social determinant of health – equitable access to physical activity in public parks. The
proposed work is grounded by the National Institute of Minority Health and Health Disparities (NIMHD)
Research Framework, and is enabled by strong partnerships between academic and community researchers,
public and private outdoor specialists, and government leaders. They are brought together to extend the work
of the Roadmap to Peace initiative. In 2013 this initiative was borne out of a community call to action following
the shooting deaths of several Latinx teens. Historically it has aimed to engage youth in healthy and healing
relationships, and currently leads “La Cultura Cura” (Culture Heals) efforts to engage BIPOC youth (through
racial/ethnic sister initiatives) in healthy and healing relationships with, and within, nature. This aligns with the
efforts of partnering outdoor specialists to increase park visits by BIPOC communities, and with the research
focus for the proposed work. Thus, a key innovation of the proposed work is a community-prioritized,
intersectoral, multilevel approach for implementing and testing a healing intervention in nature by insider
researchers committed to building sustainable systems change. The insider researchers come from the
communities being recruited to the intervention. They are committed to examining the culture of four different
communities (Black, Latinx, Pilipinx, and Pacific Islander) to test and institutionalize ideas for systems change
as part of transformative research for health equity.

Public health relevance
Cases of and deaths from most chronic diseases are disproportionally higher in communities of color. These health disparities are linked to chronic stress and the proposed research will gather knowledge about anti- racist healing in nature as a tool for stress reduction in BIPOC young adults. The culturally-appropriate, and affirming low-cost interventions that are developed will promote telomere growth to prevent health disparities.